Mechanism and Inhibition of Protein Methylation

We request an administrative supplement to the parent project to acquire an automated flash
chromatography system for use in liquid column purification of organic compounds from chemical reaction
mixtures. The equipment is important for us to synthesize enzyme inhibitors, chemical probes, optical reporters,
and various small molecule and peptide organic compounds to target enzymes and proteins of biomedical
significance. Acquiring the equipment will boost the PI’s effort to train next-generation undergraduate students
and graduate students in learning modern organic chemistry techniques.

Public health relevance
An automated flash chromatography system is essential to our research in the development of new drug molecules to target PRMTs and other epigenetic proteins. It will also assist our educational effort to train next generation undergraduate and graduate students in learning modern organic chemistry techniques.